Enabling comprehensive and user-friendly circular RNA analyses with circtools.cloud

Project Summary/Abstract
Circular RNAs (circRNAs) have been studied for only one decade but have been implicated in many different
disease settings such as cancer, neurological, and cardiovascular disease. CircRNAs are endogenous RNAs
with a covalently closed loop originating from back-splicing events of pre-mRNA, which can be detected from
raw sequencing data. Moreover, they are seen as powerful biomarkers for major human diseases due to their
stability. However, while there have been advances in computational circRNA analysis, in general, circRNA
research faces computational challenges, specifically the requirement for bioinformatics expertise, the need for
suitable infrastructure, and the location of auspicious datasets. This accessibility gap impedes researchers to
perform critical analyses and contribute to the emerging and exciting field of circRNA research. Existing
methods for circRNA detection from RNA-seq data have been in development for several years, but common
to all of them is the requirement for advanced bioinformatics expertise. Moreover, preprocessing as well as the
actual circRNA detection require considerable bioinformatics infrastructure. Each of these barriers are
significant hurdles for researchers. This proposal is the result of 8 years of circRNA research and algorithm
development. The laboratory of the PI has developed and maintains circRNA software tools that are actively
used by many researchers around the world and has analyzed hundreds of circRNA datasets. The goals of this
proposal are to substantially improve the accessibility and usability of computational circRNA research to all
researchers, independent of computational expertise, infrastructure requirements, or source of data, addressed
in three aims: 1) Develop innovative circtools modules with support for emerging approaches. New modules
will significantly enhance the capabilities of the circtools core application with a specific focus on novel
approaches, such as full-length circRNA sequencing. 2) Create a modular, multi-tool circRNA analysis pipeline
providing functional insights. We will add multiple innovative features to the circtools pipeline that will allow for
increased circRNA detection sensitivity using multiple circRNA detection tools and add functional insights using
external data sources. 3) Design circtools.cloud, a user-friendly web portal to perform comprehensive circRNA
analyses. Building on the expertise of this research team in creating R and Python-based software, the first
dedicated circRNA web application will be created to process raw and processed data. This project will unlock
computational circRNA tools for easy use by researchers who are currently unable to perform circRNA
analyses due to missing infrastructure or computational expertise. Successful completion of this project will
have an immediate and broad impact on circRNA research in human disease studies (as well as other species)
involving circRNAs.

Public health relevance
Project Narrative Circular RNAs (circRNAs) are highly relevant for public health due to their implicated role in many different disease settings and their potential as powerful biomarkers owed to their stability. This project will empower researchers to perform comprehensive computational circRNA analyses without requiring bioinformatics expertise by developing a modern, scalable, web-portal allowing them to improve human health at the forefront of genomics. These proposed advances are essential to perform robust circRNA analyses that are currently impossible due to missing infrastructure, computational expertise, or access to datasets.